HUMAN CEREBRAL GABA METABOLISM STUDIES IN VIVO WITH MR SPECTROSCOPY

We propose to study brain glutamate and GABA turnover in patients with epilepsy using combined lH and 13C NMRS. The responses to two novel anti-epileptic drugs will serve as probes to clarify the metabolic response to increased levels of GABA.